A nonpharmacological therapeutic intervention of TBI-induced facial allodynia/hyperalgesias in a rodent model

The lack of understanding of the fundamental neurobiology that underlies the development and persistence
of post-traumatic brain injury (TBI)-induced acute and chronic pain is currently unknown, further limiting our ability
to develop appropriate treatments. Electro-acupuncture (EA) is a healing modality that has been in use for years.
It's modes of action, however, are largely unknown, although there is increasing evidence that brain and spinal
cord are primarily involved in the processing of acupuncture stimuli. The analgesic effects of acupuncture are
well documented. In addition, acupuncture's powerful ability to modulate systemic inflammation during acute and
chronic events has recently been documented in multiple disease conditions. However, there is not enough
preclinical data using the procedure to initiate a clinical trial for TBI. The main objective of this proposal is to test
the dose-dependent effectiveness and mechanism of action of EA treatment to alleviate pain/headache-like
behavior in a clinically relevant rodent model of closed head traumatic brain injury (CH-TBI). This model closely
resembles blunt trauma head injury seen in human injury situations involving head impact from automobile
crashes, sports, and from blast injury received in battlefield situations. This CH-TBI rodent model exhibited
comprehensive evidence of progressive and enduring orofacial and somatic pain/headache-like symptoms
induced by non-painful stimulation. These pain/headache-like symptoms correlated with changes in several
known pain signaling receptors and molecules along the trigeminal and spinothalamic neuronal pain pathways.
Since post-TBI induced chronic pain and headache are major health issue in both military and civilian personnel,
preclinical research aiming at the exploration of underlying neurobiology, and targeted therapy is vital. Therefore,
the objective of two mechanism driven Specific Aims in this proposal is to enhance our understanding of the
neurobiology of EA therapy-influenced changes in TBI-induced pain/headache-like behaviors tested as facial
and somatic hyperalgesia/allodynia. Our recent studies using a mild CH impact acceleration TBI model in adult
Sprague Dawley rats revealed significant and enduring trigeminal and plantar hyperalgesia using a state of the
art operant orofacial and paw pain reward/conflict testing paradigm. Specific Aim 1 will evaluate the therapeutic
potential of EA therapy on the progression of TBI-induced orofacial and paw allodynia/hyperalgesias at acute
(immediate after TBI) and chronic (2 months) time points after TBI using 2 different durations (2-week vs. 4-
week) of EA therapy. Specific Aim 2 will address TBI and therapy-induced changes in mechanisms of pain
signaling in trigeminal and somatic pain pathways; these studies will quantitate of changes in a comprehensive
array of MRI-based biomarkers, molecules, and receptors related to pain signaling and inflammation in the
trigeminal and somatic pain pathways using quantitative MRI, and immunohistochemistry (IHC) based
techniques. The investigators propose that EA treatment will produce a safe, significant reduction of orofacial
and somatic allodynia/hypersensitivities; accordingly, this therapy has the potential for rapid clinical translation
as significant drug free therapy to treat TBI-induced pain and headache. Investigators further propose that the
EA treatment-induced significant reduction in orofacial and somatic pain sensitivity will be accompanied by
significant reduction of inflammatory biomarkers, and pain signaling molecules/receptors in the facial and
somatic pain pathways. MRI and IHC data will further identify details of the mechanisms of action. These studies
have the potential to increase our understanding of the neurobiology of TBI-induced pain/headache and the
mechanisms of benefits from EA, appropriate time of treatment initiation, duration of treatment, and further
provide a platform for the development of TBI-induced pain/headache treatment in both genders. We do
hypothesize that the effectiveness of EA will be maximal if it is administered acutely after injury before significant
maladaptive plasticity in pain pathways happen. Moreover, 4 weeks treatment will produce significantly better
outcomes compared to 2-week treatment due to stimuli-based enduring guided plasticity in the pain pathways.

Public health relevance
Closed head traumatic brain injury (CH-TBI) has been a major component of injury in war with lingering quality of life eroding disabilities such as chronic pain and headache that produce a substantial health care responsibility. There are also rapidly growing concerns that mild/moderate TBI is a significant risk factor for other chronic disabilities. Accordingly, there is an urgent need to increase our understanding of TBI-induced long-term disability mechanisms related to chronic pain/headache, and to test the efficacy and mechanism of potential drug-free therapy, electro-acupuncture (EA), that has excellent potential for rapid translation. This urgently needed evidence-based testing of specific mechanisms of efficacy currently limit the application of this non- addictive drug-free EA therapy to TBI-induced pain/headache. This proposed study is designed in a rodent model of CH-TBI to provide a mechanism driven neurobiological basis for TBI- and EA therapy-induced changes in pain-and headache-like behaviors as they manifest by facial and somatic hypersensitivity/allodynia.